The Boston University - UCLA Lung Cancer Biomarker Characterization Center

ABSTRACT
Screen and incidentally detected intermediate risk indeterminant pulmonary nodules (IPN) represent a clinical
dilemma for which there is little consensus about appropriate follow up due to a lack of sensitive and specific
approaches for the detection of lung cancer absent invasive tissue sampling, and concerns about costs and
harms from invasive tissue sampling in this large clinical population. Minimally invasive approaches that could
accurately reclassify individuals from the intermediate risk group (5-65% risk of malignancy) to either low (< 5%)
or high (>65%) risk would reduce uncertainty and transform the diagnostic workup of intermediate risk IPN.
Developing, evaluating, standardizing, and validating such minimally invasive biomarkers so that they are ready
for clinical use is the goal of the proposed BU-UCLA Lung Cancer Biomarker Characterization Center (BCC). In
previous EDRN-funded work we established lung-cancer associated gene expression patterns in nasal
epithelium collected with a swab from the inferior turbinate as a lung cancer biomarker. A test based on this
innovative approach to lung cancer detection is being launched for clinical use as a CLIA LDT by our long-time
collaborator Veracyte, Inc., which is participating in this BCC. We will evaluate the nasal biomarker for lung
cancer in the setting of intermediate risk IPN. To further improve the ability to clinically discriminate benign from
malignant intermediate risk IPN, the BU-UCLA Lung Cancer Biomarker Discovery Lab embedded within the BCC
will develop and test lung cancer detection approaches that incorporate detection of circulating tumor cells (CTC)
using a CLIA LDT assay from our collaborator LungLife AI, Inc. as well as blood based immune biomarkers,
advanced imaging biomarkers, and refined nasal gene expression biomarkers. We will additionally determine if
longitudinal biomarker assessment improves lung cancer detection over cross-sectional measurements.
Promising assays will be refined, standardized, and validated by the BU-UCLA Lung Cancer Biomarker
Reference Lab embedded within the BCC to advance them toward clinical adoption. These studies are enabled
by biospecimens and imaging data that are being prospectively collected from diverse populations of patients
undergoing workup for intermediate risk IPN in several large-scale ongoing clinical studies including VA LPOP,
DECAMP 1-Plus, and UCLA IDx; lung cancer research programs at UCLA and Lahey; and our EDRN
collaborators at Nashville VA and Vanderbilt. The BU-UCLA Lung Cancer BCC Team has the required multi-
disciplinary expertise in lung cancer, translational and clinical pulmonary medicine, biomarker discovery, clinical
assay development, biostatistics, clinical epidemiology, pathology, imaging, artificial intelligence, biological
sciences, bioinformatics, genomics, and complex scientific program management to accomplish these goals. An
Administrative Core embedded within the BCC will ensure that the BCC delivers on its aim to substantially
advance novel lung cancer biomarkers from discovery to clinical application and make significant contributions
to the Early Detection Research Network.

Public health relevance
PROJECT NARRATIVE Lung cancer screening by chest CT can detect lung cancer earlier and make the disease less deadly; but even among nodules that are intermediate risk, a small minority are cancerous. We will develop and validate innovative biomarkers from nasal swabs, blood, and advanced imaging analysis for determining which intermediate risk lung nodules detected via screening, or detected incidentally as part of routine clinical care, are actually lung cancers to speed treatment while minimizing invasive tests and clinical uncertainty related to benign nodules. We will partner with two molecular diagnostics companies to refine and standardize these biomarkers so that useful biomarkers can quickly be put to use.